A Learning Health System Approach to Precision Sedation and Analgesia in Critically-Ill Children

PROJECT ABSTRACT
Approximately 500,000 children suffer critical illness every year in the United States and more than one third
will receive a continuous infusion of a sedative-analgesic medication such as an opioid or dexmedetomidine.
Such drugs are commonly administered to ease the burden of critical illness by treating serious pain and
anxiety associated with invasive organ support delivery and procedures in the intensive care unit. However,
there are no widely-accepted standards for the administration of these potent neuroactive medications and
several studies have demonstrated that children receive too little or too much of these medications nearly half
of the time they are administered. This imprecision in conventional dosing strategies leads to adverse events,
including acute physiologic deterioration, drug tolerance and dependency, prolonged illness and hospitalization
and life-threatening complications of invasive support such as unplanned extubation and post-extubation
airway obstruction. Evidence also indicates that relatively short exposures to these medications may be
detrimental to long-term neurodevelopment. More precise strategies for administering these medications to
children are needed and this is an issue of major

Public health relevance
PROJECT NARRATIVE Clinicians caring for critically ill children routinely struggle to harmonize the tension between giving too much versus too little sedation-analgesia. This work will (1) identify patterns of sedation-analgesia associated with outcome; (2) identify genotypes associated with sedation-analgesia administration; (3) characterize PK parameters of common sedative-analgesic mediations; and (4) promote the development of the PI as an independent Learning Health System researcher. The aggregate results of this work will inform development of a predictive model for sedation-analgesia dose response for critically ill children that will be the focus of future, prospective investigations